Integrating 4DN data to identify functional rare variants in UDN and GTEx

ABSTRACT
Rare variants are abundant in the human population and contribute to a variety of genetic diseases. However,
identifying impactful rare genetic variants from the multitude of inconsequential variants remains a challenge.
Transcriptomics has emerged as a complementary assay to identify the effects of rare non-coding genetic
variants as approaches using gene expression outliers have assisted prioritization of rare variants involved in
rare diseases. We have previously developed a machine learning model, Watershed, to prioritize candidate
causal rare variants by integrating outlier gene expression levels with relevant genomic annotations such as
conservation and regulatory element annotations. This approach expands on variant effect prediction tools that
are genome-only by further considering an individual’s transcriptome alongside their genome in the variant
prioritization strategy. While previous approaches have focused on rare variant identification in regions
proximal to the expression outlier gene, typically within 10kb, gene expression can be regulated in part by 3D
genomic conformation. Given increasing evidence that rare variants impact DNA architecture and 3D nuclear
organization can influence the pathogenesis of rare disease, we hypothesize integrating genome topology will
enable the identification of rare variants with functional activity that are more distal to the expression outlier
gene. Our study aims to leverage Common Fund datasets to extend Watershed by utilizing 3D nucleome
information from The 4D Nucleome (4DN) Program to prioritize causal rare variants in transcriptome data from
The Undiagnosed Disease Network (UDN) and The Genotype-Tissue Expression (GTEx) Project. Our
proposed project will integrate cell-type specific and expression-matched annotations from dilution Hi-C
experiments in 4DN with RNA-Seq data from GTEx and UDN. We will assess rare variant enrichment in highly-
connected loci near gene expression outliers and develop Watershed-3D to utilize 4DN annotations to prioritize
impactful rare variants in healthy individuals and those with rare diseases. We will evaluate its performance
using N2 pairs, an approach we have previously applied to both GTEx and UDN, where two or more
individuals share the same rare variant and the predicted outlier score for one individual may be evaluated
based on the observed outlier status of the other individual(s) sharing the variant. Our outcome will be whether
3D annotations improve rare variant detection compared with previous models that do not include genome
topology annotations and prioritize impactful, long-range rare regulatory variants in UDN samples. We will
provide the genomics community with annotations for rare variants in GTEx and UDN and an expanded
Watershed-3D model in a reproducible, cloud-ready workflow. Combined, this proposal represents a significant
opportunity to integrate our emerging understanding of nuclear topology and organization with genetic
information to more systematically prioritize functional rare variant effects and their roles in health and disease.

Public health relevance
PROJECT NARRATIVE Rare genetic variants are abundant in human populations and can significantly contribute to disease risk, however, identifying causal rare variants remains a challenge. We propose to use 3D information about nuclear genome organization to improve identification of rare variants contributing to human disease risk.